Monoclonal Antibody Cocktail for Treatment of Marburg Virus Disease

Project Summary
Ebola (EBOV) and Marburg (MARV) viruses cause hemorrhagic fever disease in humans and nonhuman
primates (NHPs) with case-fatality rates as high as 90%. The 2013-2016 Ebola Virus Disease (EVD) outbreak
led to over 28,000 cases and 11,000 deaths and took an enormous toll on the economy of West African nations,
in the absence of any vaccine or therapeutic options. This outbreak spurred an unprecedented global effort for
development of vaccines and therapeutics for EVD and led to an approved vaccine and two monoclonal antibody
(mAb) therapeutics. Importantly studies with EBOV mAbs and later SARS-CoV2 mAbs established the value of
mAb cocktails for effective treatment of viral diseases. In contrast to EVD, development of therapeutics for
Marburg Virus Disease (MVD) has been lagging despite several MVD outbreaks including one in 2022. The
investigators on this MPI Phase I/II Fast Track SBIR application have developed two classes of mAbs targeting
non-overlapping epitopes within the receptor binding site (RBS) and the internal fusion loop (IFL) of MARV
glycoprotein (GP). The RBS-binding mAb (MR186), provides protection primarily through effector functions, while
the IFL-binder (R217) is the most potent neutralizing MARV mAb discovered to-date. MR186 has been
engineered to enhance bioavailability using YTE mutation in the Fc portion, and produced in a fucosyl-
transferase deficient CHO cell line to enhance effector functions (MR186-YTEAF). We are currently introducing
YTE mutations into R217 Fc to generate the therapeutic candidate R217-YTE. In this proposed project we
harness these complementary mechanisms of action to develop a highly effective cocktail of these two mAbs for
MVD treatment. Use of mAb cocktail is also expected to reduce the risk of escape variant. The proposal has four
Specific Aims. In Aim 1 (Phase I portion), R217-YTE will be produced in ExpiCHO cells and fully characterized.
Superior efficacy of the cocktail will be demonstrated in a guinea pig model of MARV-Angola and this milestone
will serve for transition to Phase II SBIR. Phase II Portion starts with Aim 2, in which the efficacy of the cocktail
will be tested in NHP models in series of adaptively designed NHP experiments and finally the superior efficacy
will be formally demonstrated in comparison with the individual mAbs. In Aim 3 we will evaluate the
pharmacokinetics (PK) and pharmacodynamics (PD) of the antibodies in sera from a number of NHP efficacy
studies including studies performed in Aim 1. Correlations between PK/PD data and clinical outcome will be
explored. Aim 4 we will be focused on generation of stable manufacturing cell lines in CHO cells and at lease
four clones of each mAb will be produced to be used for future GMP cell banks. If successful, we anticipate
further development of the product under DoD or BARDA funding and approval under FDA Animal Rule.

Public health relevance
Filoviruses are among the deadliest pathogens known to humans. The Ebola virus disease outbreak in West Africa (2014-2016), caused by the Zaire Ebola virus, resulted in over 28,000 cases and 11,000 deaths. In addition to Ebola virus, a related filovirus called Marburg has caused five outbreaks in the past 10 years with high fatality rates. This proposal is aimed at developing effective immunoprotherapeutic against Marburg virus for protection against Marburg virus disease. We have generated several antibody drug candidates that protect against Marburg infection. Under this proposal we will engineer two lead antibody to acquire long term durability after injection and we will perform animal efficacy studies with a cocktail of these antibodies. This study, if successful, will set the stage for clinical development of an effective therapeutic for human use.